BECLOMETHASONE ATTENUATION OF THE AIRWAY RESPONSE TO ALLERGEN

The purpose of this research is to compare short term effects of single doses of beclomethasone, an inhaled corticosteroid, in preventing the response to allergies.